Modulatory effects of a retinoid-related protein on intestinal endocrine cells

PROJECT SUMMARY
The gastrointestinal tract is the largest endocrine organ in the human body. This is due to the presence of
intestinal endocrine cells, a scarce yet important cell lineage within the intestinal epithelium. The hormones
produced by these enteroendocrine cells (EECs) exert important metabolic actions including insulin secretion
and appetite regulation among many others. Important examples are the insulinotropic incretin hormones
glucose-dependent insulinotropic peptide (GIP) and glucagon-like peptide-1 (GLP-1). EECs undergo
differentiation and subspecialize into sub-types characterized by a main hormonal product. However, several
factors have been reported to induce changes in EEC sub-types/hormonal profile, a phenomenon known as
plasticity. In this context, retinol-binding protein 2 (RBP2) is an important protein for intracellular retinoid
trafficking and metabolism. Although it has been described as circumscribed to the enterocytes in the small
intestine, the candidate in this proposal has reported that RBP2 along with other retinoid related proteins are
also present in EECs. Furthermore, ablation of RBP2 results in higher GIP expression and levels in mouse
studies. Gene expression of other EEC hormones is also altered. The hypothesis underlying this proposal is that
the absence of RBP2 affects EEC homeostasis and hormone expression/secretion by unique cellular pathways.
To further understand RBP2 modulatory effects in these cells, the specific aims in this research proposal will: 1)
determine the effects of RBP2 in the modulation of EEC proliferation, migration and survival and the mechanisms
involved and 2) investigate RBP2 and retinoid actions in modulating EEC populations/sub-types and hormone
secretion. These specific aims will be achieved by using specialized transgenic mouse models expressing Cre
recombinase that will allow direct EEC characterizations in global and conditional Rbp2 knockout mice. Studies
on specialized cell and organoid lines where the Rbp2 gene has been manipulated will be performed. Changes
to EEC type, distribution, proliferation, and death will be measured using immunolabeling and qPCR. Besides
unraveling the modulatory effects of RBP2 and retinoids on EECs, the proposed in vivo and in vitro experiments
will provide novel physiological insights essential to better harness the therapeutic potential of these cells. The
applicant, Dr Rossana Calderon, has designed a comprehensive 5-year training program for her career
development into an independent translational researcher. Dr Calderon is an endocrinologist by training who will
expand her knowledge in several areas including metabolic physiology, advanced cellular and molecular biology
as well as acquire technical skills in functional genomics and 3D cell culture generation and manipulations. She
will further refine her skills in scientific writing and research dissemination. This proposal will be carried out at
Columbia University, an ideal environment with vast availability of resources to support her. Dr Calderon will
count with the guidance of a multi-disciplinary mentorship team that will help her with their expertise to
accomplish her goals during the development of her project and her career towards independence.

Public health relevance
PROJECT NARRATIVE Diabetes and metabolic diseases are a global and national burden for health care with a high death toll. Hormones produced by intestinal endocrine cells exert important regulatory actions in metabolism and glucose homeostasis. The studies proposed by the candidate seek to investigate the modulatory effects of a retinoid- related protein on intestinal endocrine cell homeostasis and insulinotropic hormone production and will provide physiological insights that may help harness these cells’ therapeutic potential.